Administrative Core

PROJECT SUMMARY (See instructions): Our NIH U54 SCCPIR Center is well-integrated within the Center for Reproductive Sciences and the Department of Obstetrics, Gynecology and Reproductive Sciences at the University of California, San Francisco School of Medicine. The purpose of the Administrative Core will be to provide administrative, financial, and organizational support for the investigators and technical staff engaged in our U54 Center's research projects and supporting cores. Day-to-day operation of the Administrative Core involves and will continue to involve coordinating all administrative, financial, and compliance aspects of the award. In conjunction with the SCCPIR Center Director and the Program Administrator, the Department, and the Center for Reproductive Sciences, the Core will continue to implement an operating framework to ensure that expenditures are consistent with the intent of the award and the guidelines and regulations that govern the use of funds, as well as any institutional and federal requirements. In addition, the Core will continue to co-organize the annual Center for Reproductive Sciences Research retreat and all research meetings and presentations of our U54 investigators. The Administrative Core personnel will continue to provide full support to the PI, Project Directors, trainees, technical staff, and all Cores in our NIH U54 SCCPIR Center at the University of California, San Francisco.

Public health relevance
RELEVANCE (See instructions): The Core is highly relevant to our UCSF SCCPIR mission as it enables operationally, administratively and financially, our SCCPIR researchers, trainees and staff.